Transmission

SUMMARY – PROJECT 2
Vector control, the mainstay of malaria prevention over the past few decades, has recently become less effective
due in part to expanding insecticide resistance and changing mosquito behaviors involving more outdoor and
early-evening/dawn biting. We have designed studies with the overall goal of understanding and overcoming the
limitations of the current vector control strategies for further reductions of the burden of malaria globally, and
specifically in Malawi. First, we will assess the effects of vector control interventions on population patterns of
two important malaria parasite vectors, Anopheles funestus and An. arabiensis, in environmentally diverse sites
with different transmission intensities, using a robust dataset from historical and prospective household-level
vector sampling (Aim 1). Statistical models will also assess whether National Malaria Control Program sentinel
surveillance sites are adequately representative and informative for evaluating vector control interventions
nationwide. In another set of household-level studies, we will use human-landing catch methods to quantify the
time of day and indoor/outdoor location when Anopheles species-specific biting behavior is occurring in different
socio-ecological settings and seasons. We will then characterize the contribution of differences in the observed
vector biting patterns to Plasmodium falciparum transmission (Aim 2), using concurrent measures of people's
activity patterns, bed net use, infection status, and malaria incidence rate in coordination with the Epidemiology
Project of this ICEMR Program. We expect these analyses will identify policy-relevant risks that could tailor
implementation of existing vector control tools. These first two Aims, combined with the studies proposed in the
Epidemiology Project, will provide a valuable multidisciplinary evaluation of the current malaria prevention tools
used in Malawi. Our third Aim is designed to inform the development of potential future malaria prevention tools.
In these proposes studies, we will assess the transmission-blocking activity of novel antimalarial compounds
targeting mosquitoes under field-like conditions (Aim 3). All experiments will use field-derived, insecticide-
resistant An. funestus and An. arabiensis mosquitoes, and P. falciparum parasites currently circulating in Malawi.
We will initially assess compound uptake and stability under laboratory conditions and quantify P. falciparum
infection in mosquitoes exposed to treated net material, either with the novel compounds alone or in combination
with the insecticide deltamethrin. Additional experiments will be conducted using a screened-in experimental hut
setup, which will provide results under field-like conditions. Results will be incorporated into a mathematical
model of malaria transmission to evaluate the potential public health impact of antimalarial-treated nets. Taken
together, the proposed research program is designed to identify components of current malaria intervention
strategies that may limit their long-term effectiveness, while also assessing opportunities for improved strategies
through enhanced vector surveillance and novel interventions with unique mechanisms of action.